Mouse Models Core D

MOUSE MODELS CORE D PROJECT SUMMARY
The objective of the Cleveland DDRCC Mouse Models Core is to provide a comprehensive set of cost-effective
services and shared resources to DDRCC investigators that augments their performance of in vivo studies
focused on Mechanisms of Digestive and Liver Inflammation. The overall goal of this Core is to provide
centralized mouse modeling services that will enhance the pace of in vivo digestive and liver inflammation
research at Case Western Reserve University and the Cleveland Clinic Lerner Research Institute and provide
communal, cost-effective access to unique mouse models on intestinal inflammation and liver disease, thus
resulting in new research projects, funding opportunities, and collaborations in this area of investigation. During
the past funding cycle, the Core has been successful, with an increase in the number of Core users and several
important publications supported by the Core. The Cleveland DDRCC Mouse Models Core achieves these goals
through the following specific aims: (1) Provide experimental cohorts of SPF SAMP1/YitFc, TNF∆ARE, and
Winnie (new this cycle) mice to Center members, as well as breeding pairs to other DDRCCs and the US
scientific community; (2) Provide germ-free (GF) experimental cohorts of SAMP1/YitFc, TNF∆ARE, and Winnie
mice and microbiome-related services, including fecal material transfer experiments and GF re-derivations,
through a GF sub-core (new this cycle); (3) Educate, consult, and train DDRCC investigators in the use of various
mouse modeling techniques; (4) Provide high-resolution murine video endoscopy with well-validated scoring of
intestinal inflammation and colonic tumors; (5) Quantify murine intestinal inflammation by 3-D stereomicroscopy
with assessment of myeloperoxidase activity. The Core steering committee meets monthly to discuss operational
issues, and the core director presents its operations to the DDRCC Executive Committee at their quarterly
meetings to evaluate the effectiveness of existing services against the evolving needs of the DDRCC
membership, assuring that the Core brings the most benefit to Center investigators and the scientific themes of
the Cleveland DDRCC. Thus, the DDRCC Mouse Models Core benefits its members by providing uniquely
available resources and cost-effective services that facilitate the development of research related to digestive
and liver inflammation in the Cleveland scientific community and nationally.